Technology Core

Project Summary
CORE 2: TECHNOLOGY CORE
The mission of the NIH-funded Atlanta Center for Microsystems Engineered POC Technologies (ACME POCT)
is to assist and enable inventors from across the country who have developed microsystems-based POC
technologies in defining their specific clinical needs, refining their technology and conducting clinical validation,
with the objective of accelerating the path to translation and clinical adoption.
The Technology Core of the ACME POCT will identify, select, and manage a portfolio of microsystems-based
POC technologies at different development stages and support their technology development/refinement. In
particular, the Technology Core is responsible for developing the annual project solicitation with input from the
clinical needs assessment performed within the Dissemination Core and in close coordination with the CTSC.
Working with the CTSC, the Technology Core will oversee the review process of submitted applications and,
after project selection by the NIH, manage funded technology development/refinement and testing projects.
Moreover, the Technology Core of ACME POCT will serve as the technology refinement laboratory for the POC
technologies supported by the center. In this role, the Technology Core facilitates technology
development/refinement projects by connecting project teams, as needed, with design and engineering
expertise, and providing access to state-of-the-art design, microfabrication, and prototyping capabilities, which
will be expanded over the course of the program. Finally, the Technology Core will work closely with Clinical
Core to facilitate access to clinical validation, usability, and regulatory resources available to the project teams.